Structure and functions of the actin cytoskeleton

Summary
In this Administrative Supplement for Equipment application, I request funds to purchase an upgrade for the
superresolution DeepSIM fluorescence microscopy system to perform advanced subdiffraction imaging at the
high technological level demanded by the current state of the field. This equipment is needed to achieve goals
of the parent grant R35 GM 140832 entitled “Structure and functions of the actin cytoskeleton”.

Public health relevance
Project narrative Cutting edge technology is critical for productivity and reliability of scientific research, which is the principal way to find new diagnostic and treatment tools to fight human diseases.